DLA Pharmaceutical Prime Vendor (PPV) Program

The PPV contract enables DAIT/ NIAID to purchase brand name pharmaceutical products (ie: biologics) at a significantly discounted (50-60% cheaper) price for clinical trials where the institute holds the IND.